PRC2 independent role of Ezh2 in regulation of basal cell dynamics post-influenza virus infection

Project Summary:
Influenza is a major global health threat causing over half a million deaths each year. Certain virulent strains,
such as H1N1, can cause extensive lung damage, leading to dysplastic repair and the formation of Krt5+ basal
cell pods in the damaged alveolar. Despite their temporary barrier restoration capabilities, these basal cells fall
short in facilitating full tissue repair, resulting in the accumulation of dysplastic tissue and compromised lung
function. The abnormal repair process mirrors patterns seen in chronic lung diseases like idiopathic pulmonary
fibrosis (IPF) and chronic obstructive pulmonary disease (COPD), accentuating the urgency to understand the
cellular and molecular mechanisms governing lung remodeling and repair. Using mouse models exposed to the
influenza A virus strain PR8, we and others have demonstrated that these nascent basal cells predominantly
originate from a rare subset of migratory airway cells. Furthermore, we found that Enhancer of Zeste 2 (Ezh2) is
marked upregulated in the hyperplastic basal cells post-PR8 infection. Conventionally, Ezh2, as the catalytic
subunit of the Polycomb Repressive Complex 2 (PRC2), has been recognized for its ability to repress gene
expression via the trimethylation of lysine 27 on histone 3 (H3K27me3). However, these basal cells post-PR8
infection showed lower H3K27me3 levels compared to nearby cell types, aligning with low expression of other
PRC2 components like Eed. This implies a potential PRC2-independent function for Ezh2 in controlling basal
cell hyperplasticity. Additionally, Ezh2 deletion in airway epithelial progenitor cells led to marked reduction Krt5+
pod after PR8 infection. Moreover, we also observed a significant upregulation of Sox9 in the hyperplastic basal
cells post-PR8 infection. Sox9 deletion also led to reduction of the Krt5+ pod area mirroring Ezh2 deletion
phenotype after PR8 infection. Furthermore, inhibition of Ezh2 resulted in suppressed Sox9 expression in basal
cells both in vivo and in vitro, suggested Ezh2 may serve as a transcription activator for Sox9. Based on these
data, our central hypothesis is that Ezh2 functions in a PRC2-independent manner to regulate basal cell
dynamics post-PR8 infection. In Aim 1, we will investigate whether the phosphorylation-mediated non-canonical
role of Ezh2 plays a regulatory function in basal cell dynamics following PR8 infection. In Aim2, we will identify
the unique gene targets of non-canonical Ezh2 and ascertain whether Sox9 serves as an integral downstream
effector in basal cells post-PR8 infection. In Aim3, discern the interacting partners external to the PRC2 complex
with which Ezh2 associates to exert its non-canonical role in basal cells post-PR8 infection. Additionally, we seek
to identify the factors that initiate these interactions and changes. Completion of these aims will provide
transformative insights into the mechanisms underpinning lung tissue remodeling post-influenza and the broader
implications for pulmonary medicine.

Public health relevance
Project Narrative: Influenza, especially aggressive types like H1N1, can severely damage lungs, leading to dysplastic repair and the formation of Krt5+ basal cell pods in the damaged alveolar. Our research is centered on a protein, "Ezh2", which appears to diverge from its conventional role within the Polycomb Repressive Complex 2 (PRC2) to uniquely regulate basal cell behavior following influenza infection. The goals of this proposal are to study the unique role of Ezh2 in regulating basal cell dynamic post severe influenza infection and aim to offer insights into improving lung repair following influenza infections and potentially other lung diseases.